Using Mobile Technology to Examine Mechanisms Linking Sleep and Smoking Cessation

PROJECT ABSTRACT
Tobacco use disorder is the most common substance use disorder. Cigarette smoking is highly concentrated among
individuals with low socioeconomic status (SES); however, they often lack access to smoking cessation services. Thus,
smoking cessation in low SES adults remains a critical public health concern that warrants further study and
attention. Smokers attempting to quit are at the highest risk for lapse within the first weeks of their quit attempt, and an
initial lapse is highly likely to lead to full relapse. It is essential to identify and understand behavioral factors that may
increase or decrease the likelihood of successful smoking cessation among low SES adults during a quit attempt (pre-
and post-quit). Recently, sleep dysregulation, such as insufficient sleep duration, has been considered as a potential
intervention target to improve smoking behavior (e.g., number of cigarettes smoked per day) and smoking cessation
outcomes (e.g., abstinence). On the other hand, studies have found the lower SES is associated with higher rates of
poor sleep. Thus, SES must be accounted for when assessing sleep dysregulation and smoking behavior and cessation
outcomes. Although previous studies have examined the relationship between sleep dysregulation and smoking
behavior and/or cessation outcomes, they have several methodological limitations, including the use of retrospective
survey methods, not using the integrated sleep health dimensions (usually only sleep duration or quality), use of cross-
sectional surveys, laboratory-based data collection, omitting low SES smokers, and focusing on a single pathway rather
than dynamic associations. Therefore, this proposal will use a Real-Time Data Capture approach among low SES
smokers who are attempting to quit. This approach will involve a granular examination of the bidirectional and temporal
association of daily sleep dysregulation and smoking cession processes (pre- and post-quit) using smartphone-based
ecological momentary assessment (EMA) and wearable sensors among low SES smokers. Specifically, we aim: 1)
During the pre-quit period, to examine the within-person and between-person effects of sleep dysregulation on smoking
behavior and cessation and 2) During the post-quit period, to identify bidirectional and temporal associations of daily
smoking abstinence and sleep dysregulation via EMA and wrist-worn sensors during the first four weeks of a smoking
cessation attempt. The proposed research and training plan will take place at Rutgers Cancer Institute of New
Jersey. Training will focus on increasing knowledge of the understanding and measuring of sleep dimensions,
health disparities in smoking cessation studies, and application of advanced mHealth technologies (including
EMA and actigraphy data analyses techniques). It is expected that completion of these aims will yield the
necessary preliminary data for developing and implementing Just-in-Time-Adaptive Interventions (JITAI) that aim to
improve sleep health during smoking cessation.

Public health relevance
PROJECT NARRATIVE The proposed project will be among the first to examine the bidirectional and temporal associations between daily sleep dysregulation and smoking behavior and cessation outcomes using intensive longitudinal data via EMA and wearable sensors during a scheduled smoking cessation attempt among socioeconomically disadvantaged smokers. A better understanding of the relations between sleep dysregulation, smoking behavior, and smoking cessation will inform the development of novel interventions that address sleep dysregulation in smokers seeking cessation among socioeconomically disadvantaged smokers.